Career Enhancement Core

PROJECT SUMMARY - CAREER ENHANCEMENT CORE
The goal of the Career Enhancement Core (CEC) is to foster the development of researchers planning to
engage in the field of tobacco regulatory science (TRS). The CEC will oversee the career development of 6
current early-career faculty (some of whom are Project co-Leaders), 2 new faculty recruits (funded with
institutional support), and 8-10 postdoctoral fellows, in addition to graduate and undergraduate students. OSUTCORS
has a strong track record of career enhancement. During TCORS-I, we trained 4 early-career faculty (2
of whom received an NIH career development award) and 7 postdoctoral fellows, 5 of whom are in faculty
positions conducting TRS research or in research/policy positions focused on TRS. Our investigators have
trained numerous other early-career faculty, post-doctoral fellows, graduate, and undergraduate students in TRS
since TCORS-I as well. The OSU-TCORS early-career faculty, postdoctoral fellows, and students will have the
opportunity to work in a rich research environment with experienced mentors and robust mentoring and career
enhancement infrastructure. They will conduct their research within the projects and have opportunities to
propose and conduct pilot projects within our Theme “Flipping the Script”: Using the Industry’s Nicotine
Playbook to Maximize Public Health. Research and training experiences will be anchored in TRS
competencies to provide trainees with opportunities to engage in science on the impact of nicotine dimensions
(source/isomer, form, concentration) on the appeal, addictiveness, and toxicity of nicotine and tobacco products.
The Specific Aims are to: 1) develop a structured training program on TRS that includes lectures, readings,
journal clubs, and seminars; 2) deliver this training program to early career faculty and postdoctoral fellows
engaged in OSU-TCORS projects, with complementary training in grant writing and exposure to professional
development activities; 3) provide opportunities for graduate and undergraduate students to participate in OSUTCORS
research projects, professional development, and special program initiatives; 4) conduct continuous
process evaluation and annual outcome evaluation of the center and provide feedback to Principal Investigators,
the Executive Committee and the External and Internal Advisory Boards; and, 5) oversee the OSU-TCORS
research pilot studies program, directed to the trainees, which will allow for the completion of preliminary studies
for future grant applications. The CEC will be led by Drs. Amy Ferketich and Darren Mays, who have experience
leading training and educational programs. They will oversee the development and implementation of the training
program, the summer undergraduate research program, the research pilot studies program, and the evaluation
of CEC activities. Training the next generation of researchers is critical to the success of the TRS and the FDA
CTP mission. The OSU-TCORS CEC proposes varied set of research activities and has a strong track record of
mentorship in TRS.

Public health relevance
The tobacco industry has historically manipulated nicotine in its products to increase their appeal and potential for addiction for the widest possible audience, including young people and non-users. They are now doing this with newer products, like e-cigarettes and oral nicotine pouches. Our center will study how these manipulations affect young people and adults, with the goal of helping the FDA develop regulations that will make these products less appealing to young people, including non-users, but not older adult smokers and smokeless tobacco users who may benefit from their use.